Tissue-immunoengineering of TMJ neodisc implants

PROJECT SUMMARY
Temporomandibular joint (TMJ) disc perforations pose devastating morbidities for millions of Americans.
Interventions to slow or prevent progression of this disease do not exist. Toward addressing this as-of-yet
intractable problem, tissue-engineered neodisc constructs made with allogeneic costal chondrocytes have
shown promise in healing TMJ disc thinning, but larger defects remain a major challenge. Due to the exposed
allograft area, larger defects elicit a more severe immune response compared to smaller defects, necessitating
novel approaches to engineer TMJ neodisc constructs for large defects typically associated with TMJ disc
perforation. Novel tissue-engineering strategies, termed “tissue-immunoengineering” in this proposal, are set
forth, where TMJ neodisc constructs are cocultured with macrophages to improve construct functional properties
(i.e., biochemical and mechanical properties), toward achieving TMJ disc healing in vivo. Pro-healing and anti-
inflammatory M2-polarized macrophages will be examined for their effects on enhancing the robustness and
resilience of TMJ neodisc constructs. Prior work for enhancing tissue-engineered constructs has used bioactive
agents, such as growth factors and chondrogenic conditioned media, but no studies have introduced coculturing
constructs with macrophages to improve TMJ neodisc properties. Macrophages have been shown to direct
healing through secretions and their reactions to changes in tissue composition and stiffness during healing. A
potential mechanism for the coordination of TMJ disc healing is the bidirectional interaction between
macrophages and chondrocytes, resulting in continuous adjustments to changes in the healing
microenvironment. Despite their potential, the utility of M2 macrophages, including both pro-healing or M2a (i.e.,
stimulated with IL-4/IL-13) and anti-inflammatory or M2c (i.e., stimulated with IL-10) subtypes, have not yet been
examined for enhancing the suitability of engineered tissues for implantation. Collaboration between the
Athanasiou and Liu laboratories recently showed that improving construct functional properties not only results
in mechanical durability but, also, excitingly, resistance to immune-mediated degradation. Moreover, exciting
new scRNA-seq results from this collaboration are providing insights as to how macrophages and chondrocytes
communicate to coordinate tissue formation. Encouraged by these novel and significant results, we propose to
test the hypothesis that coculturing TMJ neodisc constructs with M2-polarized macrophages in vitro will increase
functional properties of the constructs, thus, improving healing outcomes in large perforation TMJ disc defects
in vivo. This overall hypothesis will be examined through three aims: 1) To identify the macrophage origin and in
vitro activation conditions that maximize functional properties of TMJ neodisc constructs. 2) To tune the
mechanical environment of macrophage-construct direct coculture systems to improve construct functional
properties through a) direct mechanical stimulation and b) enhancement of M2 macrophage polarization. 3) To
improve the healing of large perforation defects of TMJ discs in a minipig model using a tissue-
immunoengineered TMJ neodisc construct. It is anticipated that this proposal will establish a novel and robust
tissue-immunoengineering strategy to improve healing of the TMJ disc, with the potential to improve the lives of
millions living with TMJ disc perforation.

Public health relevance
PROJECT NARRATIVE Current therapies for perforation of the temporomandibular joint (TMJ) disc are limited in addressing this debilitating condition, which affects 9M people in the United States. Tissue-engineering using allogeneic cells has shown promise in addressing this significant unmet clinical need, but the tissue-engineered allografts needed to address large TMJ disc perforations have been associated with a more severe immune response compared to those needed for smaller defects. The proposed work aims to develop a tissue-immunoengineering approach for generation of large TMJ neodisc constructs, which, if successful, would not only improve TMJ disc healing, but also inform tissue-immunoengineering approaches for other tissue applications.